Genetics of zebrafish germ layer formation

Work focuses on the writing of senior-author manuscripts describing unpublished work on zebrafish embryonic development stemming from Feldman and his colleagues' research from 2004-2012. Feldman also 1) maintained mutant zebrafish lines relevant to germ layer formation studies: cyclops and one-eyed pinhead. 2) Read and assessed the following articles in the field in his capacity as a member of the Developmental Biology/Pattern Formation Section of Faculty Opinions: MicroRNAs Establish the Right-Handed Dominance of the Heart Laterality Pathway in Vertebrates.